Administrative Core

PROJECT SUMMARY – Administrative Core
The Administrative Core is responsible for organizing and supporting three research projects and three
scientific cores in this Program. The Core provides leadership, infrastructure, and support personnel to
facilitate administrative management; promote integration, communication, and collaboration; ensure fiscal and
regulatory compliance; and oversee data operations, scientific rigor and research progress. The Administrative
Core will oversee the Program's organizational infrastructure and day-to-day administrative activities; serve as
the liaison with all internal and external constituencies; provide clerical support for document preparation;
foster team science by facilitating collaboration and communication through regular meetings, seminars, and
other interactions; provide fiscal management to ensure timely financial accounting and reporting according to
university and NIH policies; provide regulatory support to ensure compliance with institutional, state, and
federal research guidelines; oversee data operations to ensure use of best practices for data provenance and
integrity (e.g. monitoring standards such as SOPs, GCP, GMP); provide scientific management by monitoring
research progress/productivity and effective use of shared resource cores relative to scientific milestones and
budgeted expenditures; conduct rigorous Program evaluations, with guidance and direction provided by
Internal and External Advisory Boards; manage resource sharing and conflict resolution; and delineate specific
publication and data distribution policies. By serving these functions, the Administrative Core reduces
administrative burden, allowing the Program investigators to focus on developing novel immunotherapies for
patients with glioblastoma (GBM).